Evaluate the role of extracellular vesicles in tumor microenvironment modulation

PROJECT SUMMARY
In the United States, it is estimated that >100,000 people will die from non-small cell lung cancer (NSCLC) in
2024. Emerging targeted therapies, such as checkpoint immunotherapies have resulted in significant success;
still, 50% of patients treated with anti-PD1 or anti-CTLA4 have poor clinical efficacy. The effectiveness of
immunotherapies has been strongly correlated with the abundance of immune T cells in the tumor stroma.
Indeed, increased T cell infiltration is a strong prognostic indicator across 17 solid cancer types, including
NSCLC. Nonetheless, immunotherapies have largely remained ineffective in tumors that have reduced T cell
infiltration, also called immune-cold tumors. Therefore, understanding the mechanism(s) that lead to reduced
tumor infiltrating T cells is of significant interest in the treatment of immunosuppressive NSCLC.
Despite an extensive understanding of T cell suppression mechanisms in immune-cold NSCLC, current therapies
have shown modest clinical benefit, indicating that additional mechanisms contribute to this process. One such
emerging mechanism is tumor-derived extracellular vesicles (EVs), however, identification of specific EV
subpopulations responsible for T cell suppression has remained a challenge. Overcoming this challenge, we
have identified a specific subpopulation of NSCLC-derived EVs, called TGN46+ EVs, that strongly inhibit the
proliferation of T cells. In an immunosuppressive NSCLC model (H358), total H358 EVs inhibit T cell proliferation;
however, specifically depleting TGN46+ EVs from total H358 EVs significantly reduces their ability to suppress
T cells. Our findings are clinically relevant, and we have further verified them in two independent NSCLC models
as well as in prostate cancer, which are well-known to form immune-cold tumors. Given these findings, we
hypothesize that TGN46+ EVs play a key role in modulating T cell tumor infiltration in immune-cold tumors.
In the proposed work, we plan to evaluate how this single EV subpopulation, i.e. TGN46+ EVs, influences T cell
infiltration and overall tumor microenvironment. To evaluate this, we will use (i) a humanized mouse model that
supports the development of the human immune system and allows the study of human-specific tumor-immune
interactions; (ii) a human NSCLC model (HCC827) that exhibits high T cell infiltration in humanized mice, and
(iii) EVs from an immunosuppressive NSCLC model (H358). We will evaluate how T cell infiltration and
abundance of other immune cell types in HCC827 tumors change upon introduction of (i) total H358 EVs (which
includes TGN46+ EVs), or (ii) H358 EVs depleted of TGN46+ EV subpopulation, in the tumor stroma.
Following the successful completion of this study, we anticipate that we will have evaluated EV-specific
modulation of the tumor microenvironment and its physiological implications. These accomplishments would
have an enormous positive impact on our understanding of intercellular communication in immune-cold NSCLC.
In the long term, these insights have the potential to inform the development of effective strategies to overcome
immunotherapy resistance, thereby benefiting a considerable number of lung cancer patients.

Public health relevance
PROJECT NARRATIVE In the United States alone, >100,000 people are estimated to die from lung cancer in 2024. The successful completion of the proposed studies will uncover novel mechanism(s) that contribute to therapy resistance. In the long term, these insights have the potential to inform the development of effective strategies to overcome therapy resistance, thereby benefiting a considerable number of lung cancer patients.